Admin Core

ADMINISTRATION – PROJECT SUMMARY/ABSTRACT
The University of Virginia Cancer Center (UVACC) Administration Team provides the infrastructure and
support to enable the UVACC to function effectively, efficiently, and cohesively. The Administration Team is led
by Dina Gould Halme, PhD (Associate Director for Research Administration) and has staff with expertise in
financial management, grants administration, general administration, research development, and philanthropy.
The members of the team work with UVACC leadership to foster collaborations and support cancer-focused
research through infrastructure, Pilot Research Projects, and faculty recruitment.

Public health relevance
Project Narrative: Per PAR-20-043, Project Narrative is not completed.